Changing the Narrative on Firearms Violence: A Community Collaborative Intervention

ABSTRACT
Homicide, typically with a firearm, is the third leading cause of death for young people ages 10-24 in the U.S.,
disproportionally affecting African-American and other minority youth, particularly young males. In the District
of Columbia, violent crime is up 28% from 2021, and homicide rates rose 14% between 2020 and 2021, with
the highest impact in socioeconomically challenged communities. To address this serious public health issue,
the Prevention and Community Health Department within the George Washington University Milken Institute
School of Public Health (GWSPH), together with Mint, Inc., Don’t Shoot Guns, Shoot Cameras, DC Housing
Authority/Highlands Addition Community Center, the DC Office of the Attorney General, and the DC Office on
Gun Violence Prevention/Building Blocks, propose to collaboratively finalize, implement and evaluate a highly
unique, community-level youth firearms prevention intervention in two phases – a developmental UG3 Phase
One, and an implementation UH3 Phase Two. The proposed intervention, called “Changing the Narrative on
Firearms Violence,” involves a unique, theory-driven effort to develop and disseminate multiple media featuring
alternative, non-violent identity trajectories, with actualization of those trajectories facilitated through a
community support process. Specifically, the proposed project will: 1) Collaborate in all phases with the CLIF-
VP as a cooperative agreement; 2) In Phase One (UG3), conduct formative research to finalize intervention
elements, including identification of potential non-violent identity and branding attributes and identification of
key community communication channels; finalize composition of the Community Steering Committee; and
development/pilot testing of data collection instruments and protocols; 3) In Phase Two, implement the
intervention, collect baseline and two rounds of follow-up survey data in a community sample of youth ages12-
16 and a parent/guardian for each surveyed youth, collect qualitative data to understand intervention effects,
analyze the data, share data and results through the CLIF-VP, and disseminate results in collaboration with
community partners and the CLIF-VP.

Public health relevance
This cooperative agreement project entails formative research to finalize intervention elements and data collection protocols, followed by the implementation and evaluation of a unique community-level intervention to prevent firearm violence among youth in a Washington, DC community.